Molecular mechanisms of endocytic initiation and cargo selection

Abstract
The primary route of internalization from the plasma membrane is clathrin-mediated endocytosis (CME), which
is required for vital cellular processes such as signaling, nutrient uptake, and development. While the molecular
mechanisms underlying the late stages of vesicle formation are well studied, the mechanisms underpinning the
earliest stages of endocytosis, including initiation and cargo selection, are poorly understood. Initiation and cargo
binding are largely controlled by the AP2 clathrin adaptor complex, a core component of the vesicle coat that
serves as a bridge between the rigid clathrin lattice and membrane-embedded cargo. However, it is unclear how
AP2 discriminates between hundreds of potential cargo in a complex membrane environment, while also
responding to spatial and temporal regulatory cues. While >50 proteins are proposed to regulate or be required
for CME, and many physically interact with AP2, we have little mechanistic and structural data for how they are
regulated during the earliest stages of endocytosis. We propose that multiple unique AP2 conformations, driven
by association with regulatory factors, control higher-order AP2 functions such as cargo selection. Understanding
the nature of the regulatory mechanisms controlling endocytosis is critical, as CME largely controls the
localization of many medically-relevant proteins such as RTKs and GPCRs. This proposal therefore seeks to
reconstitute and define the molecular mechanisms of AP2-mediated endocytic initiation and cargo sorting.
Current models of endocytosis largely rely on biochemical experiments performed with soluble components and
live cell imaging. Importantly, our methodology is focused on modifying all experimental approaches — cryo-EM,
biochemical reconstitution, and single molecule fluorescence microscopy — to include a membrane, thereby
addressing a critical need to develop mechanistic models in a near-native membrane environment. This
approach is poised to provide an understanding of the role of membrane-induced allostery in driving regulatory
decision-making during endocytic initiation. This proposal will focus on two broad areas of endocytic regulation
— cargo selection mediated by the conserved Muniscin family proteins, and a quality control checkpoint
controlled by a single phosphorylation mark on the μ2 subunit of AP2. As diseases associated with endocytic
defects are likely caused by missorting of important trans-membrane cargo, our insights into the mechanisms of
endocytic initiation and cargo selection will enable hypothesis-driven research into disease model systems and
drug development.

Public health relevance
Project Narrative Clathrin-mediated endocytosis is the primary route of internalization from the plasma membrane and is required for cell viability and the proper response to extracellular cues like growth factor signaling. Mutations in the endocytic machinery, or the proteins that regulate this process, lead to a variety of diseases like cancer and neurodegeneration. This research will take an interdisciplinary approach to understand the mechanisms of endocytic initiation and cargo selection to understand CME in normal cells and how it is subverted in human disease.